Biostatistics and Data Management Core

BDM Core Summary/Abstract
The Biostatistics and Data Management (BDM) Core will be responsible to provide PPG4
projects and investigators with a broad range of statistical and data management expertise. The
BDM Core will be responsible for creating, maintaining and seamlessly integrating all collected
data (clinical, imaging, biomarkers) in this PPG4, as well as the statistical analysis proposed for
each project (correlations, linear regression, path analysis, longitudinal analysis, high-
dimensional associations). The BDM core will closely work with the PPG4 Investigators and
provide datasets and analysis for each specific hypothesis and will provide investigators with
datasets upon request in a format that is easy to use with any statistical analysis program. The
BDM Core will work closely with the Imaging Biomarkers Methodology (IBM) Core to facilitate
the efficient transfer of raw and processed PET and MR images and imaging outcomes
(measures of cortical thickness, regional volumes, and cerebrovascular disease burden) so that
the BDM Core can provide data analysis as well as interpretation and dissemination of
associations related to imaging outcomes. Similarly, the BDM core will facilitate the integration
of the rest of the outcomes (that are not-high-dimensional), cognitive, blood, etc. collected from
the other cores to be integrated in the database and used in subsequent analyses. BDM Core
will hold weekly Core meetings to discuss data integration in the database, data requests,
analysis plans as well as general methodology issues as they arise. The BDM Core will provide
training to students, post-doctoral fellows, and faculty in data analysis with focus on analysis
methods used in the PPG. In addition, the BDM core will organize monthly seminars with a
focus on specific topics with instructional purposes for graduate students and postdocs involved
in the PPG4.